The Affordable Care Act: MCV/PCV & Pertussis

DESCRIPTION (provided by applicant): This grant will supplement epidemiology and laboratory capacity within the Tennessee Department of Health Emerging Infections Program (EIP) to help meet several critical public health needs. We are requesting a new Public Health Administrator 2 to function as a senior administrative manager for all EIP activities. This person will have responsibility for oversight of grant management, fiscal reporting, personnel and administrative coordination among all EIP programs and studies. We will hire a new epidemiologist who will have responsibility for coordination of data management activities across EIP programs and sites, as well as coordination with CDC regarding interoperability issues. They will be responsible for ensuring that EIP is appropriately represented and integrated in state-level efforts to improve electronic laboratory reporting and hospital communicable disease reporting in the context of national eHealth initiatives. Funding is requested to support quarterly webinars for surveillance staff and health department epidemiologists statewide on EIP-related topics. We will offer training on the use of NHSN to infection prevention staff at all Tennessee hospitals. In addition to these core capacity-building efforts, Tennessee will continue to actively participate in EIP Influenza projects, and launch a new program for surveillance of bloodstream infections in dialysis patients (DA-BSI). For influenza activities, two additional surveillance officers (one full-time, one part-time) will expand outreach with specific attention to obtaining specimens from catchment hospitals for rRT-PCR diagnosis. The overall objective of the DA-BSI study is to develop sustainable methodology for surveillance and to describe the epidemiology of DA-BSI. Standardized reporting and knowledge of DA-BSI epidemiology will allow for the development and evaluation of interventions to prevent them. We will hire a nurse who will actively participate in protocol development with CDC, and travel to dialysis centers participating in the validation study for on- site chart reviews.

Public health relevance
Patient Protection and Affordable Care Act (PPACA) Emerging Infections Program (EIP) Enhancing Epidemiology and Laboratory Capacity (U01) Background and Understanding The Tennessee Department of Health (TDH) and Vanderbilt University School of Medicine work in close partnership with the Tennessee Emerging Infections Program (EIP). FoodNet surveillance, which began in 1999, is performed statewide, covering 135 hospitals in 95 counties with a population of 6.2 million. Most Active Bacterial Core Surveillance (ABCs) projects are performed in the major metropolitan areas of the state, and the catchment areas for special studies and influenza projects vary depending on study requirements. Tennessee EIP Principal Investigators (PI) and staff have actively participated in all aspects of EIP activities, and have taken leadership roles in a number of studies. For example, Tennessee chairs the FoodNet Outbreak Working Group, proposed and leads the Hemolytic Uremic Syndrome/Shiga- toxin producing E. coli (HUS/STEC) Genomics Study, and has taken the lead in analysis and publication of studies on infant salmonellosis, drug-resistant S. Newport outcomes, foodborne disease outbreak data, and a Shiga-toxin producing E. coli cohort study. The Tennessee EIP site has a strong record of participating actively in proposing, developing and implementing projects and protocols, which requires PIs who are closely engaged in the program. Tennessee PIs have traditionally considered EIP activities a high priority, and devoted substantial time and attention to supporting them at both the state and national levels. Drs. Jones, Schaffner, Dunn, and Kainer participate actively in national working groups and activities directly related to EIP work, speaking and publishing frequently in support of the EIP mission. Tennessee uses the National Electronic Disease Surveillance System (NEDSS) Base System (NBS) as the core of its disease reporting management systems. While each EIP study involves additional databases, all studies, whether based primarily at the State health department or Vanderbilt University, depend on efficient coordination and integration with Department of Health data management programs (including the State laboratory's StarLIMS, Bionumerics, and electronic laboratory reporting (ELR). Interoperability with the Centers for Disease Control and Prevention (CDC) and other information technology systems is also imperative. The Department of Health is in the midst of rapid and dramatic changes in its information technology (IT) infrastructure, much of which is being driven by ELR and national healthcare-associated infections (HAI) activities. These changes are affecting EIP relationships with infection preventionists (IPs) and the medical facilities at which our surveillance activities occur. The Tennessee EIP has been an active participant in influenza projects since the 2003-04 influenza season. Dr. Schaffner serves on the Influenza Activity Steering Committee. Surveillance of patients in all age groups admitted to hospitals with laboratory-confirmed influenza was conducted by the Tennessee EIP through the influenza season ending in 2010. Laboratory testing to identify influenza subtype by real-time polymerase chain reaction (RT- 1 PCR) was pursued. The EIP influenza surveillance sites also serve as a platform to conduct influenza vaccine effectiveness (VE) studies. The Tennessee Department of Health is currently involved in the healthcare-associated infections and antimicrobial use prevalence survey. We have successfully obtained IRB approval, enrolled sites, coordinated training of infection preventionists with the CDC, and started data collection. TDH will also be participating in the denominator simplification project and has been communicating with CDC and other EIP sites regarding the design of this study. Tennessee has mandated the use of the National Healthcare Safety Network (NHSN) for reporting of HAIs by hospitals since 2008 and, using funds from the American Recovery and Reinvestment Act (ARRA), has been able to recruit and train additional staff in NHSN surveillance methodology and definitions. The ARRA-funded EIP HAI staff includes one epidemiologist, one nurse, and a part-time administrative support assistant. Dr. Marion Kainer, the Director of Tennessee's HAI program, is an infectious diseases physician and healthcare epidemiologist who served as an Epidemic Intelligence Service officer in CDC's Division of Healthcare Quality Promotion, where she performed an evaluation of the Dialysis Surveillance Network. Dr. Kainer is also Tennessee's representative on the EIP steering committee for HAI- related activities. TDH has a strong interest in surveillance of dialysis-associated blood stream infections (DA-BSI). Although we have explored avenues to conduct surveillance for dialysis-associated events using NHSN in outpatient dialysis centers in Tennessee, resource limitations at the dialysis centers have not permitted us to initiate this surveillance to date; however, analysis of data from Tennessee's surveillance of invasive methicillin-resistant Staphylococcus aureus (MRSA) infections highlighted the exceptionally high risk of infection among dialysis patients. In Tennessee, the incidence of invasive MRSA among diabetics on dialysis was 300 times greater than among non-diabetics not receiving dialysis. Additionally, the incidence of invasive MRSA among blacks is 1.9 times that of whites in Tennessee, and 73% of this racial disparity could be explained by the higher prevalence of diabetes and dialysis among blacks. Invasive MRSA is the third most common reportable communicable disease in Tennessee, and dialysis patients are one of the groups at highest risk for invasive MRSA infections. Given the high mortality of these infections, TDH is committed to preventing dialysis-associated bloodstream infections, including those caused by MRSA. The Communicable and Environmental Disease Services (CEDS) Section of TDH has extensive experience working closely with healthcare facilities and other institutions on several projects pertaining to HAI prevention and surveillance. Through the CDC Emerging Infections Program, we contract with the Vanderbilt University School of Medicine to perform active surveillance for invasive pathogens at all hospitals in the major metropolitan areas of Tennessee. TDH also maintains existing contracts with the Tennessee Hospital Association (THA) for the hospital discharge database. THA initiated and supports the Tennessee Center for Patient Safety (TCPS), which has three HAI prevention collaboratives underway regarding central line- associated bloodstream infections (CLABSIs), surgical site infections (SSIs), and MRSA infections. TDH is an active partner and supporter of TCPS. We are issuing a request for proposals to facilitate electronic reporting of laboratory data to public health and reporting of HAI data to NHSN. These existing close relationships and contracts provide an important platform for addressing new HAI prevention activities promptly and efficiently statewide. Currently, there is no state-mandated surveillance in non-acute healthcare settings apart from reporting of invasive MRSA, vancomycin-resistant Enterrococci (VRE), and isolates of 2 vancomycin-intermediate or -resistant Staphylococcus aureus (VISA or VRSA) from any site; all outbreaks are reportable. TDH however, has worked with the Tennessee Healthcare Association (THCA - the trade organization that represents nursing homes) to provide educational training on at least seven occasions in the last three years on HAI, MRSA, CDI, and pandemic influenza. TDH has assisted several long-term care facilities and dialysis centers in the investigation of outbreaks of multi-drug resistant organisms (MDROs) or other adverse events. Furthermore, Dr. Marion Kainer is a member of all four local Association for Professionals in Infection Control (APIC) chapters in Tennessee and has provided educational training, lectures, and workshops at their meetings. Each APIC chapter includes members from non-acute care settings, and Dr. Kainer has made an effort to include topics of interest to those members. The TDH HAI program also has a very close, long-standing relationship with Q-Source, Tennessee's quality improvement organization (QIO) (see appendix 1). Tennessee's QIO has strong relationships with all types of non-acute healthcare facilities, including dialysis centers. In fact, Tennessee is the lead state for the chronic kidney disease (CKD) pilot project funded by the Centers for Medicare & Medicaid Services (CMS). We will engage Network 8, Inc., in a partnership to facilitate this study. Network 8, Inc., is a non-profit organization which provides services to kidney patients and their providers under federal contract with CMS. Core activities include quality improvement, technical assistance, education, information management, and resolution of patient and facility complaints and concerns. All outpatient dialysis centers in Tennessee are members of Network 8. We will also provide education to Network 8 by presenting Tennessee aggregate data on DA-BSI at the organization's annual conference. 3 Need Activity 1: As EIP activities have expanded dramatically in recent years, to include not only FoodNet and ABCs but also influenza, healthcare-associated infections, encephalitis, C. difficile, HPV, etc. The need for core infrastructure, including increased administrative support and dedicated PI time, has increased concomitantly. In addition to project-specific staff, there is a critical need for sufficient personnel to manage overall grant budgets and administration, coordinate activities between project sites, contribute actively to conference calls and meetings, and take leadership roles in EIP projects. Currently, Tennessee does not have a dedicated high- level administrative supervisor with the ability to oversee and coordinate administrative functions across all EIP programs. Tennessee has demonstrated its capacity and enthusiasm for being actively involved in all EIP activities, and additional resources are urgently needed to maintain this level of participation. Activity 2: Many Tennessee EIP activities rely heavily on the participation and support of local and regional health department staff and hospital IP personnel. It is critical that as the demands on their time increase, the EIP program provides these partners with ongoing education and training to maximize their capacity to participate. There is an important need for training health department staff on general EIP-related infectious disease topics, providing training on outbreak response to field staff, and helping train IPs on use of NHSN and other information technology. There is also a need for basic reference materials on EIP-related infectious diseases. Activity 3: The changes in the Department of Health IT systems noted above are making it imperative that the Tennessee EIP site establish a position for an epidemiologist with expertise in data management to coordinate IT activities among EIP projects. While this person will not supplant staff currently collecting study-specific data, the EIP program currently does not have the infrastructure and support to ensure that each of our projects are effectively integrated into NBS, StarLIMS and other essential resources, and appropriately taking advantage of improvements in ELR. It is critical that information systems used within EIP are interoperable across EIP activities and with CDC, are Public Health Information Network (PHIN) compliant, and are effectively integrated with other larger changes occurring in the national healthcare information-management environment. Activity 4a (Influenza): In previous years, the case definition for EIP influenza surveillance relied upon the documentation of influenza by a variety of tests that were available to physicians at their hospitals. The substantial majority of tests were rapid influenza diagnostic tests (RIDTs). However, the RIDTs performed substantially more poorly in diagnosing the novel 2009 H1N1 pandemic virus. Indeed, their sensitivity and specificity were so low that some physicians and institutions actively discouraged use of RIDTs for diagnostic testing. These circumstances highlighted the important role of real-time reverse transcriptase polymerase chain reaction (r RT-PCR) testing. However, because r RT-PCR testing capacity was available almost exclusively only at the Tennessee Department of Health Laboratory, methods had to be developed for specimens to be obtained from patients admitted to surveillance hospitals with influenza-like illness and then have the specimens transported to the State laboratory. The Tennessee population-based influenza surveillance network consists of 20 hospitals located in Davidson County (Nashville) and seven surrounding counties (population under surveillance 1.5 million). All hospitals have provided excellent cooperation with our influenza 4 surveillance activities since 2003. However, it was evident that cooperation during the 2009- 2010 influenza season required substantially more diplomatic attention from our surveillance staff and was not always successful. Much reliance was placed on the hospital's infection preventionists to identify candidate patients and to acquire the specimens. Both the EIP program and the Tennessee Department of Health provided much information and resources to the surveillance hospitals; nevertheless, acquiring specimens for submission to the State laboratory strained the capacity of some hospitals in the surveillance network. The infection preventionists in some hospitals could not do this consistently and, indeed, the largest hospital in the surveillance network could not commit to this level of collaboration because of staff shortages in their infection control program. Therefore, there is a need for additional dedicated EIP surveillance staff who would have two functions: to maintain and enhance the influenza diagnostic activities in already- collaborating hospitals, and to perform case-finding and specimen acquisition activities in the large hospital. Activity 4b (Dialysis BSIs): TDH has long recognized a need to perform surveillance in dialysis centers. The dialysis patient population is increasing, and there has been a 29% increase in DA-BSI since 1993. Furthermore, there has been an increase in hospitalizations for BSI from approximately 8.2 per 100 patient-years in 1999-2000 to 10.5 per 100 patient-years in 2005- 2007. Infections are the second leading cause of death among dialysis patients with vascular access infections accounting for 57% of infections. A dialysis patient has 0.9 to 2.0 catheter related BSIs per year. Phase 2 of the Department of Health and Human Services' (HHS) national action plan to prevent healthcare-associated infections will focus on outpatient dialysis centers and ambulatory surgery centers. TDH plans to target dialysis centers in phase II (rather than ambulatory surgical centers) because of the high morbidity and mortality associated with infections in dialysis patients and the demonstrated burden of MRSA infections among this patient population. A total of 150 outpatient dialysis centers exist in Tennessee; of these centers, DaVita and Fresenius operate 46 and 55 centers respectively, and Dialysis Clinics Incorporated (DCI) operates 27. We hope that utilizing existing electronic laboratory and health record data obtained by CDC from Fresenius and DaVita, will provide a standardized and efficient method for recording dialysis-associated bloodstream infections. Validation of these data will be important in moving forward with automated case finding approaches in dialysis centers. Our proposed catchment area includes a total of 32 outpatient dialysis centers (11 Davita centers and 21 Fresenius centers). These centers are located in 14 counties (see appendix 2). The census at these centers ranges from 20 to 120. 5 Operational Plan Activity 1: The Tennessee EIP program will hire a Public Health Administrator 2 as a senior manager for all EIP activities. The process for establishing this new position will begin immediately on notification of this grant award. The position will be based in the CEDS Section of the Department of Health, which encompasses all programs involved in EIP activities. This person will also work closely with administrative and program staff at the Vanderbilt EIP site. This senior administrator will have responsibility for oversight of grant management, fiscal reporting, and personnel and administrative coordination among all EIP programs and studies. Activity 2: The Tennessee EIP program will conduct quarterly webinars for surveillance staff and health department epidemiologists statewide on EIP-related infectious disease topics. We will offer training on the use of NHSN to IP staff at all Tennessee hospitals. To provide positive feedback to EIP partners, we will continue to hold an Annual EIP Scientific Day program for participants from across the state, and provide CME and CEUs for attendance. Activity 3: The Tennessee EIP program will establish a new Epidemiologist position immediately on notification of this award. This person will serve as the senior coordinator of information technology systems. They will work directly in the State Epidemiologist's office at the Department of Health (the State Epidemiologist also serves as the EIP PI). In this position, the new epidemiologist will be able to coordinate data management activities across all EIP programs, as well as ensure that EIP is appropriately represented and integrated in state-level efforts to improve ELR systems and hospital communicable disease reporting. This epidemiologist will not replace staff currently working on program-specific data, but will have responsibility for coordination of activities across programs and sites, as well as coordination with CDC regarding data management and interoperability issues. They will work closely with the State's PHIN Coordinator to ensure that all EIP activities meet and maintain the most current state and national standards for interoperability. Activity 4a (Influenza): The two requested additional surveillance officers in the contractual budget for Vanderbilt University Medical Center (one full-time, one part-time) will expand and enhance the influenza surveillance activities with specific attention to obtaining specimens for r RT-PCR diagnosis. In particular, the new full-time person will develop relationships in the large hospital such that newly admitted patients will be identified for specimen acquisition. This will involve contacts with the admitting office, the infection preventionists, the laboratory and others. Training will be performed rapidly and efficiently by the current EIP staff. Activity 4b (Dialysis BSIs): The TDH EIP-HAI Study Coordinator is Dr. Matthew Crist. Dr. Crist, along with Dr. Kainer and Anne Massieu, a nurse on the HAI team with prior experience conducting TDH surveys in dialysis centers, will actively participate in protocol development with CDC. We will hire a nurse who will travel to dialysis centers participating in the validation study with on-site chart reviews. We anticipate that data collected will include type of access, antibiotic treatment, and whether the patient was hospitalized or died. Pending protocol development, patients in dialysis clinics will be surveyed regarding recent hospitalizations, infections, and other relevant information, and referring hospitals will be contacted to find cases of DA-BSI not captured through centralized laboratory reporting. Dr. Crist will provide analytic and statistical support to ensure data quality and will assist with enrolling dialysis centers and answering questions from participating study sites. 6 The overall objective of the study will be to develop sustainable methodology for surveillance of DA-BSI and to describe the epidemiology of DA-BSI. We plan to determine the sensitivity, specificity, and positive and negative predictive values of this methodology pending development of the final protocol. We also hope to determine the accuracy of specific data fields, such as access type, source of culture collection, and at-home versus in-center dialysis. Determination of the accuracy of electronically captured denominator data will also be a potential objective and will be explored in protocol development. Meeting these objectives will be a critical step toward 1) developing standardized and efficient methods for reporting DA-BSI and 2) describing the epidemiology of these infections. Standardized reporting and knowledge of DA-BSI epidemiology will allow for the development and evaluation of interventions to prevent DA-BSI. Timeline " August-September 2010: Participate in protocol development. " September 30, 2010: Earliest anticipated start date of award. " October 2010: Hire nurse and submit Institutional Review Board (IRB) application. " November 2010: Train nurse and obtain IRB approval. " December 2010: Obtain permission from Davita and Fresenius and enroll a minimum of 20 dialysis centers. " December 2010: Establish dialysis center group on the online HAI workspace (see appendix 4). " December 2010-January 2011: Perform validation of dialysis-associated bloodstream infections for the previous quarter. " January 2011-July 2011: Continue data validation. " August 2011- December 2011: Work with CDC on analysis and presentation of the data. TDH will work with CDC to prepare reports on the aggregate rate of dialysis-associated bloodstream infections per 100 patient-months in Tennessee and across all participating EIP sites. TDH will also report the correlation between infections reported through automated data collection systems and those identified through validation efforts. The target audience for these reports will include professionals in both infection control and dialysis center communities. TDH will communicate the results of these reports via abstract presentations at infection control meetings, such as those held by SHEA and APIC. We will disseminate information to providers of outpatient dialysis services through oral presentations at the Network 8 annual meeting and to regional corporate meetings of DaVita and Fresenius that are attended by facility administrators. We will provide further education to dialysis nurses and dialysis technicians by giving oral presentations at cannulation camps (sponsored by QSource), where individuals are trained in proper techniques for accessing lines, fistulas, and grafts (see appendix 3). The TDH HAI section maintains a secure online workspace hosted by the NING network, (see appendix 4). We will encourage contacts from dialysis centers to join this workspace and will create a group on the workspace for the DA-BSI study. This HAI online workspace has been very popular among infection preventionists and quality improvement specialists in Tennessee (163 active members). 7 Measures of Effectiveness Because two new personnel will be providing core infrastructure support across programs, their primary activities will ensure that the specific measures of effectiveness within each EIP program or study are successfully met. Activity 1: The Senior Administrator will ensure that: 1) 100% of Cooperative Agreement applications and reports are submitted by the required deadlines to CDC, 2) all contractual partners are audited appropriately according to state regulations and meet 100% of grant and contract requirements, 3) state and contractor fiscal records are up-to-date, available to CDC and auditors on a timely basis, and reviewed by EIP PIs at least quarterly, and 4) EIP administrative personnel are managed to ensure that each program and study is appropriately supported. Activity 2: Provide webinars twice per year, and face-to-face meetings twice per year, for all health department epidemiologists and EIP surveillance staff, on EIP topics. Activity 3: The new senior Epidemiologist will ensure that: 1) all EIP project information systems meet 100% of current PHIN standards, 2) EIP information systems effectively utilize ELR within 90 days of any changes successfully implemented by the Department of Health's Office of Information Technology Systems, 3) EIP interests are consistently represented on committees and in meetings at the state and national level concerning implementation of electronic medical records (EMR), "Meaningful Use" standards, Health Information Partnership- TN (HIP-TN) development, and similar initiatives, and 4) training for all EIP surveillance officers and epidemiologists is provided at least quarterly on these issues of information technology interoperability. Activity 4a (Influenza): The ratio of specimens submitted for r RF-PCR testing to the number of patients admitted with suspected influenza will be the principal measure of effectiveness. Other measures are those related to the ongoing influenza projects including completeness and accuracy of chart reviews as well as number of controls identified for the vaccine effectiveness project. Activity 4b (Dialysis BSIs): 1. Hire a nurse to conduct data validation within one month of notification of the award. 2. Train the nurse within one month of hiring. 3. Enroll a minimum of 20 of the 32 DaVita and Fresenius centers within a 100-mile radius of TDH within 3 months of notification of the award (will target all 32). 4. Establish a communications network with the enrolled dialysis centers within 4 months of notification of the award using the HAI online workspace, hosted by NING (see 3E). 5. Complete validation and case report forms on at least 95% of positive blood cultures within one month of the end of each quarter. 6. Answer specific research questions agreed upon by the relevant EIP committee/working group by December 2011 (if that is the established timeline). 8 Human Subjects Institutional Review Board (IRB) approval will be obtained from CDC, the Tennessee Department of Health, Vanderbilt University School of Medicine, and any other applicable institutions for any studies involving human subjects, according to federal regulations. The Vanderbilt IRB determined the influenza project poses minimal risks to participants. This study meets 45 CFR 46.110 (f)(4) for expedited review. This project was deemed "Public Health Practice: Evaluation of the Routine Surveillance" by CDC and Tennessee Department of Health IRBs. 9 Budget A detailed line-item budget is attached as required in the appropriate grants.gov form and includes a detailed, specific justification for each requested expenditure. 10